CANCER IN ORIENTAL POPULATIONS

Studies of Oriental populations represent the Division's continuing interest in the health risk among these minority groups for the mapping out of cancer prevention and control programs: . A critical review of mortality/incidence statistics in the PRC is being conducted to ascertain their usefulness for analytic purposes, and for planning of future studies of cancer-related diseases. . A time-trend study on cancer/non-cancer mortality was made of U.S. Chinese, by nativity. Compared to the host (U.S. white) and homeland populations (Hong Kong, Singapore, Taiwan). . Assembling mortality/incidence figures on Asian populations from various sources, we are establishing an international file of cancer/non-cancer causes since 1960. These Asian resource data, age-adjusted and age-specific rates, also include figures for U.S. and "homeland" populations. . A companion mortality study of Chinese migrants to Taiwan and Singapore from Fujian to those who originated in Guangdong and settled in the U.S. and Hong Kong is being completed. . Future plans include: a comprehensive analysis of mortality patterns of migrant Chinese and Japanese at geographic, generational, and temporal levels, including mortality transition among Chinese in Taiwan, and among U.S. Japanese; extension of nativity analyses of U.S. Asians to cancer incidence; and in cooperation with the Surveillance and Operations Research Branch to revise the SEER ethnic coding to separately identify Koreans, Vietnamese and Asian Indians.